GAIT ANALYSIS IN MEDICAL REHABILITATION

DESCRIPTION (Adapted from Applicant's Description): Human Motion Analysis serves as an important clinical tool for rehabilitation, pre-surgical planning, post-surgical follow-up, and long term evaluation of treatment in those with gait disorders. In order to present the latest clinical and technical advances in human motion analysis, funds are requested to partially support a Mini-Symposium entitled, "Symposium on Gait Analysis in Medical Rehabilitation" which will be held in conjunction with the 19th Annual International Conference of the EKE Engineering in Medicine and Biology Society in Chicago (October 28-November 2, 1997). The Mini-Symposium will be planned as part of an all-day workshop for approximately 80-100 attendees, and will provide state of the art information on rehabilitative and orthopaedic applications, as well as scientific. and technical advances and anticipated future developments. It will also provide vital information on multi-center study planning and assessment in the field of rehabilitative human motion analysis. The ultimate objective of the Mini-Symposium and Workshop is to: 1) provide a forum for planning and coordinating future rehabilitative motion analysis studies, particularly those with a multi-center clinical focus, 2) educate/update all attendees on recent and anticipated technical developments, 3) review recent and emerging clinical developments in rehabilitative care, and 4) document the clinical and technical proceedings of the meeting through publication of an authoritative, edited proceedings. The goal of the Mini-Symposium and Workshop is to establish a cooperative infrastructure for multi-center study and motion analysis data-sharing with a special focus on rehabilitation issues in gait analysis. New and emerging technical resources which can facilitate an interactive multi-center environment will be highlighted. The Mini-Symposium and Workshop is planned as a special tutorial within the IEEE/EMBS Annual Meeting and will have no other meetings scheduled at the same time. A plenary session will consist of two main speakers who will introduce and survey the topics. Following the plenary session, the subsequent presentation and breakout sessions will address the appropriate issues in greater depth. During the course of the one day meeting, ten subject areas will be highlighted.